Retroviral RLI/4-1 BBL and RLI/FLT3L Combination Immunomodulatory Gene Therapy for Glioblastoma

PROJECT SUMMARY/ABSTRACT
This proposed project is within the scope of R01NS123808. There are no changes to the Project
Summary/Narrative of the Parent Award. A brief description of the Parent Grant Specific Aims is provided
within the Research and Career Plan.

Public health relevance
PROJECT NARRATIVE This proposed project is within the scope of R01NS123808. There are no changes to the Project Narrative of the Parent Award.